A Safety and Efficacy study of AAV2-hAADC for AADC deficiency

? DESCRIPTION (provided by applicant): AADC deficiency is a genetic disorder. It is caused by errors, or mutations, in the gene for AADC. The gene mutations lead to malfunction of the AADC protein. AADC is an enzyme that is essential for the production of specific chemical signaling molecules, or neurotransmitters: dopamine, serotonin, norepinephrine, and epinephrine. When AADC does not work properly, a person cannot produce normal levels of these neurotransmitters. Symptoms result from a state of neurotransmitter deficiency in the brain and the body. The purpose of this gene transfer study is to test a new, experimental treatment for AADC deficiency. The intervention will attempt to provide corrected copies of the human gene for AADC (hAADC) directly into brain cells in one specific region of the brain, the midbrain. The gene will be introduced via a gene vector, which is a specially modified virus (adeno-associated virus type 2, AAV2) that can carry the gene into brain cells. The gene and the vector are combined to make the gene transfer agent, known as AAV2-hAADC. The procedure will involve direct injections of AAV2-hAADC into the brain. Once the gene is inside brain cells, we expect that the body will use its own natural mechanisms of making proteins to make functional AADC enzyme.

Public health relevance
PUBLIC HEALTH RELEVANCE: This first-in-children clinical trial aims to partially correct a genetic deficiency of a key enzyme (AADC) needed to synthesize certain key neurotransmitters (Dopamine, Norepinephrine, and Serotonin) in the brain. Children with AADC Deficiency require constant care that exacts a disproportionate economic, social and human cost on society. The proposed intervention will deliver a recombinant adeno-associated virus carrying the human AADC gene into the dopamine-producing cells in the brain.